HIV Clinic-based Screening for Geriatric Syndromes in Older Adults with HIV

PROJECT SUMMARY AND ABSTRACT
Older people with HIV (PWH) experience more comorbidities and are at increased risk for geriatric syndromes
at relatively younger ages than their peers without HIV. However, identification and management of geriatric
syndromes in PWH remains a clinical challenge in HIV care. The frequency of geriatrics assessment as part of
routine HIV care for older PWH has not been reported. Furthermore, no studies to date have rigorously evaluated
implementation of such assessments integrated in clinics dedicated to the care of PWH (HIV clinics). To address
this gap in clinical care, we will use implementation research and user-centered design to implement and
evaluate an HIV clinic-based screening intervention for 2 key geriatric syndromes in this population, cognitive
and physical function impairment. The Montefiore Center for Positive Living (CPL) provides care to over 2,800
PWH per year, approximately half of whom are aged 50 years old or older. CPL clinic staff will be trained to
administer evidence-based screening assessments of cognitive and physical function and will be educated on
appropriate follow-up care for all PWH aged 50 years old or older who receive continuity care in the clinic.
Specifically, we aim to: 1) utilize user-centered design to select implementation strategies for the screening
intervention and process with key stakeholders, 2) evaluate the implementation outcomes of the screening and
care pathway protocol for physical function impairment and memory loss among older PWH, and 3) identify
contextual factors associated with variability in implementation outcomes among patients, providers, and other
clinic staff. With co-mentorship from an interdisciplinary team of researchers, Mary Clare Masters, MD/MSCI,
seeks to build upon her previous clinical research experience at the intersection of HIV and aging. Dr. Masters
will receive training in implementation science, qualitative and mixed research methods, participatory research
with a focus on inclusion of vulnerable populations (particularly older adults who have cognitive or physical
function impairment) and addressing social determinants of health, and advanced leadership skills. Her long-
term research goal is to become an independent investigator focused on implementing scalable and sustainable
interventions to reduce functional and cognitive impairment and promote resilience among older PWH. The
integrated research infrastructure at Albert Einstein College of Medicine and Montefiore Medical Center will
facilitate achievement of her academic goals. Future research directions include evaluating this intervention’s
impact on clinical outcomes and retention in appropriate care and its scale-up to additional sites. These data are
essential to inform the most appropriate strategies for sustaining and expanding HIV geriatric programs in the
future.

Public health relevance
PROJECT NARRATIVE Older people with HIV (PWH) are at increased risk for geriatric syndromes at relatively younger ages than their peers without HIV, but identification and management of such syndromes remains a clinical challenge in HIV care. This proposal will use implementation research and user-centered design to implement and evaluate HIV clinic-based screening for impaired cognition and physical function at the Montefiore Center for Positive Living (CPL). The results from this investigation will inform best practices implementation of screening for geriatric syndromes in PWH, linkage to appropriate specialty care, and appropriate strategies for sustaining and expanding HIV geriatric programs in the future.